NJDA AFRPS Maintenance Grant

NJDA AFRPS Maintenance Phase – Project Summary/Abstract
The broad objective of why the NJDA is applying for AFRPS Maintenance funding to continue to
maintain and improve upon all 11 Standards found therein. Since beginning the implementation
of the Standards 5 years ago, the NJDA’s Feed Program has improved greatly.
In order to continually improve the program, as the

Public health relevance
NJDA AFRPS Maintenance Phase – Project Narrative This project will help to directly reduce public health risks by sampling for pathogens in animal feed and pet food, which are handled by commercial agricultural workers, as well as homeowners. It will also reduce indirect risk causing illness in animals, which are subsequently consumed, handled or otherwise come in contact with humans.